LAMB Request for equipment to be used in VA Animal Research Facility

This equipment request concerns two items that will be of great value to our animal research program. The Surgical Microscope will allow our two newly renovated operating rooms to be used simultaneously. At present, our single surgical microscope is shared by 8 different VA funded projects. The Digital X-Ray will allow investigators working with implanted devices to confirm the location of these devices over time. The X-Ray will also be of value to our veterinary care staff, in the ongoing care of research animals.

Public health relevance
This is an equipment request to acquire two instruments for use in the animal research program of the Louis Stokes Cleveland VA Medical Center. One item is a Surgical Microscope. While we have available two newly renovated operating rooms, we have a single microscope with suitable resolution and stability for the ongoing studies. In addition, this microscope must be shared across 8 different VA funded projects. While our investigators have been patient in sharing this instrument, the acquisition of a second high quality microscope would accelerate research progress. The Digital X-Ray will allow investigators working with implanted devices to confirm the location of these devices over time. The X-Ray will also be of value to our veterinary care staff, in the ongoing care of research animals.